Impact of hyperglycemia on the pathogenesis of chronic bacterial lung infection

Abstract
Muco-obstructive airway diseases (MADs) are chronic, life-threatening conditions that cause more than 3 million
annual deaths worldwide. MADs are characterized by excess mucus accumulation in the airways, inflammation,
chronic infection, and progressive respiratory failure. Pseudomonas aeruginosa (Pa) is the primary bacterial
pathogen associated with MADs infections. Pa colonization leads to declining lung function, reduced quality of
life, and decreased life expectancy in people with MADs. Diabetes is a frequent comorbidity affecting 18-50% of
individuals with underlying MADs. Diabetes is associated with worse MADs clinical outcomes and increased
susceptibility to severe pulmonary infections. In addition, diabetes is associated with increased antibiotic
treatment failure in individuals with MADs. Utilizing novel in vitro and in vivo model systems, we have observed
increased virulence potential and higher tolerance to antibiotic treatments in Pa under diabetic MADs-like
conditions. These observations raise several questions such as how the diabetic microenvironment in MADs
induces Pa virulence and how it leads to higher rates of antibiotic tolerance. We hypothesize that diabetic
hyperglycemia in the lung microenvironment enhances bacterial fitness and potentiates bacterial
virulence. We further hypothesize that hyperglycemia alters bacterial metabolism towards increased
tolerance to antibiotic therapies. We will address these questions in both in vitro systems that reflect the MADs
and diabetes lung environment and in a diabetic murine chronic infection model of MADs. This proposal will
address key research areas including the influence of diabetes comorbidities in Pa virulence and antibiotic
treatment failure in MADs.

Public health relevance
Narrative Muco-obstructive airway diseases (MADs) are a major cause of morbidity and mortality worldwide and chronic Pseudomonas aeruginosa infection increases lung damage in individuals with MADs. Diabetes is a frequent comorbidity in MADs that potentiates P. aeruginosa virulence and antibiotic treatment failure. This proposal will examine the mechanisms driving worse outcomes in chronic diabetic lung infection with P. aeruginosa.